Administrative Core

ABSTRACT
Administrative Core
The Administrative Core is the central organizational entity of our proposed Center for Environmental and
Health Effects of PFAS. The goals of the Administrative Core are to ensure integration and efficient
administrative and fiscal management of the Center to stimulate discovery-based knowledge and
facilitate research translation that leads to improved protection of environmental and human health.
The leadership team is purposefully comprised of individuals with domain-specific expertise that reflects the
biomedical and environmental science and engineering foci of the Center as well as significant administrative
experience and strong connections to government stakeholders to ensure effective and efficient management
and research translation. An internal advisory committee (IAC) will be formed with a designated representative
from each of the Research Projects, Cores, and the community of Center trainees. This committee will be the
voice of the Center and work with the Administrative Core to facilitate and implement initiatives and develop
content (e.g., community partner meetings, annual Retreat, transdisciplinary seminars) that will ensure and
strengthen communication and integration within and outside of the Center. In addition to providing planning
and administrative support on a day-to-day basis, a dedicated Center Program Manager will solicit information
from all members and coordinate the development and dispersal of current and dynamic content for public-
facing communication mechanisms such as the Center's web site and social media feeds. Research
Translation will be a priority of the Center. The collective strength of existing partnerships with government
stakeholders among the Center's members will be leveraged, shared, and expanded according to clear
timelines and development of Individualized Research Translation Plans by all Center members during the first
year of funding and in coordination with the Center's Research Translation Coordinator. Plans will be revisited
bi-annually and will evolve as the Center and research programs progress. The Administrative Core will work
closely with the Community Engagement Core (CEC) and facilitate Center member involvement in a range of
activities including bimonthly community meetings throughout the impacted regions of priority for this Center,
the Center's annual Retreat, reviewing CEC mini grants, and cultivating research collaborations with
community partners and Fellows. Finally, the Administrative Core will work with the Research Experience and
Training Coordination Core to ensure integration of Center trainees with Research Projects and Cores,
development of nanocourses, scheduling of seminars embedded in transdisciplinary seminar series, and
involvement of trainees in IAC meetings and the annual Retreat. The Administrative Core will provide the
infrastructure and support to facilitate and continually evaluate and implement integration-cultivating measures
and collaboration to reach the goals of the Center.

Public health relevance
NARRATIVE Administrative Core Per- and polyfluoroalkyl substances (PFAS) are environmental contaminants of emerging concern because they are detected ubiquitously in our environment, yet there is little known about their toxicity, bioaccumulation, or effective remediation strategies. The Administrative Core of this proposed Center will be responsible for ensuring coordination and efficient administrative and fiscal management of the Center to stimulate discovery- based knowledge, and to facilitate research translation and help to inform preventive actions by community and government stakeholders to protect human health.